TISSUE SPECIFIC TRANSCRIPTION IN THE B LYMPHOCYTE

This application for a Physician Scientist Award proposes rigorous and extensive training in molecular biology as a foundation for a career in experimental hematology and oncology. Formal didactic work will consist of graduate level courses and seminars in molecular and cell biology, genetics, immunology and virology at the Massachusetts Institute of Technology, Harvard Medical School and Harvard University. Dr. Phillip A. Sharp, Professor and Director of the Center for Cancer Research at MIT will serve as sponsor, supervising intensive research in transcriptional regulation of immunoglobulin gene expression in the B lymphocyte. The focus of the experiments proposed is the identification and functional characterization of proteins which may interact with known transcription factors to orchestrate the tissue-specific expression of immunoglobulin genes in B cells. If successful, this work will have important implications not only for the regulation of gene expression in normal and malignant cell lines but also for the currently unsolved problem of producing human antibodies in vitro. Progress during Phase I will be monitored by a commitee of physicians and scientists selected by Dr. Sharp and Dr. John Potts, Chief of Medicine at the Massachusetts General Hospital. A specific project for Phase II is not yet formulated, however, reserach on gene expression such as that proposed in this application should easily lend itself to the study of any number of human neoplastic disease states.